Comparative Data Analytics Core

Project Summary (Comparative Data Analytics Core)
Researching aging biology presents unique methodological challenges. To maximize the impact of aging
research, it is essential to have a wide range of statistical expertise within and supporting research teams.
The Comparative Data Analytics Core (Analytics Core) is dedicated to advancing aging research through
statistical support and methodological innovation, offering unique expertise in rigor, reproducibility, and
transparency. The Analytics Core serves a diverse portfolio of personnel, from NSC pilot award winners to
other investigators in the field, by implementing rigorous design and analysis protocols and supporting
investigators to meet high standards of rigor and transparency. Our team also engages in developing avant-
garde methods to bring new techniques to the field. Our specific aims include providing statistical support to
UAB and non-UAB investigators studying the comparative energetics of aging, utilizing traditional,
specialized, and bespoke methods; conducting high-level statistical investigations of secondary data to
answer questions about the comparative energetics of aging; developing and evaluating statistical methods
needed in the field of comparative energetics of aging; and offering reproducibility, verification, and
transparency support for aging researchers. In this renewal, to enhance research quality and culture, we
also introduce a 'red team' approach, where our team critically evaluates research designs and analysis
plans from volunteer research teams to identify potential methodological weaknesses before publication.
This proactive strategy aims to prevent errors, thereby reducing the need for post-publication corrections and
enhancing the field's reputation. In addition to these Core activities, we focus on training and fostering
interdisciplinary exchange among researchers. Our efforts are aligned with the NIA’s objectives, particularly
in fostering interdisciplinary research, enhancing collaboration, and developing the infrastructure necessary
to translate research findings into practical interventions. By fostering rigorous, reproducible research, the
Analytics Core will catalyze more informative research, advancing our understanding of aging biology. Our
previous funding cycle demonstrated significant success, supporting investigators from 27 unique institutions
and contributing to numerous completed projects and publications. We aim to build on this success by
continuing to provide high-quality statistical support, developing innovative methods, and ensuring research
rigor and transparency.